Extracellular Matrix Regulates Hepatic Stellate Cell Activation and Fibrosis

Project Summary
Liver fibrosis is the consequence of chronic liver diseases, such as hepatitis B and C infection, alcohol-
associated liver disease, and metabolic dysfunction-associated steatotic liver disease. Cirrhosis, the end stage
of liver fibrosis, is the 11th leading cause of death in the US. To develop effective anti-fibrotics for liver fibrosis,
we need a better understanding of the molecular basis of liver fibrosis. Prior to our study, hyaluronic acid (HA)
was only known as a non-invasive biomarker for liver fibrosis. In the previous funding period, we determined
that HA is actively synthesized by upregulated HA synthase 2 (HAS2) in activated hepatic stellate cells (HSCs)
in liver fibrosis. HA synthesized by HAS2 is then converted to lower molecular weight (LMW)-HA, which
activates CD44, TLR4, and Notch1 signaling, thereby activating HSCs for liver fibrosis progression. Although
LMW-HA is critical for the development of fibrosis, the mechanisms of LMW-HA formation during liver fibrosis
and HA-mediated fibrosis are still poorly understood. In the renewal application, we will characterize these
mechanisms. The central hypothesis of this renewal application is that TMEM2, a newly identified
hyaluronidase, mediates the production of extracellular LMW-HA that promotes liver fibrosis via fibrotic
phenotypic changes in HSCs and liver sinusoidal endothelial cells (LSECs). Using cell-specific TMEM2
deletion mice, Aim 1 will determine the mechanism of extracellular HA catabolism by TMEM2. Aim 2 will
determine the regulation of TMEM2 expression by focusing on two transcription factors, HIF1α and SOX4, in
hypoxic and fibrotic environments. Because both HSCs and LSECs highly express CD44, a HA receptor, Aim 3
will determine the downstream effector pathways activated by HA and TMEM2 in HSCs and LSECs for liver
fibrosis development. Aim 3 will also investigate whether the crosstalk between LSECs and HSCs is crucial for
the HA-TMEM2-CD44-mediated HSC activation and fibrosis progression. We anticipate our results will provide
valuable insights into the poorly understood mechanism of regulation of the profibrogenic activity of HA and its
effect on HSCs and LSECs in the development of liver fibrosis. This will improve our understanding of the
clinical value of HA, not only as a biomarker for liver fibrosis but also as a cause of liver fibrosis and a target for
effective treatments.

Public health relevance
Project Narrative Liver fibrosis is the consequence of chronic liver diseases, such as hepatitis B and C infection, alcohol-associated liver disease, and metabolic dysfunction-associated steatotic liver disease, and to date, there is no effective anti- fibrotic agent for treating liver cirrhosis, thus, effective treatments for liver fibrosis and cirrhosis are desperately needed. Prior to our study, hyaluronic acid was only known as a non-invasive biomarker for liver fibrosis, and in the previous funding period, we determined that actively synthesized hyaluronic acid promotes stellate cell activation and liver fibrosis. In this renewal application, we will further determine the mechanism of hyaluronic acid catabolism as the mechanism of hyaluronic acid-mediated liver fibrosis.